Investigating the Role of Lipid Droplet Docking in Lactation Initiation and Milk Secretion

PROJECT SUMMARY
Milk is a complex fluid capable of providing total nutrition of the human infant for 6 months or longer, as well as
enhanced protection against infection and common childhood illnesses during the critical early postnatal period.
Successful initiation of lactation, called secretory activation, requires hormonal signaling that initiates synthesis
and secretion of milk products in secretory mammary epithelial cells and stimulates contractile activity in
surrounding myoepithelial cells. Disruptions from maternal obesity, premature birth, or delivery-related stresses
are associated with impaired secretory activation and poor lactation performance. Since there are no available
treatments for low-milk supply, it is critically important to continue to explore basic molecular mechanisms of
mammary gland biology and milk secretion. Specific aims in this proposal explore (1) the role of milk fat secretion
in secretory activation, (2) the crosstalk between the secretory cells and myoepithelial cells at secretory
activation, and (3) how obesity disrupts milk fat secretion and secretory activation. The proposed studies use
mouse models of obesity, quantitative intravital and super-resolution imaging, exploratory and hypothesis-driven
omics studies and innovative physiological models to define the cellular mechanisms involved in secretory
activation. Genetically modified mice and pharmacological agents will be used to modify specific signaling
pathways which may stimulate or inhibit milk secretion. The resulting information will provide a new paradigm for
understanding the causes of delayed initiation of lactation in humans, allowing the development of evidence-
based strategies to address lactation insufficiency and increase breastfeeding success rates.

Public health relevance
PROJECT NARRATIVE Breastfeeding provides neonates with essential nutrients, but few mothers in the United States breastfeed their children for the recommended length of time due to failure to either initiate or maintain lactation, leading to degraded infant and maternal health. This project elucidates the cellular and molecular order of events of milk secretion, determines factors which regulate it and directly investigates how obesity, a major cause of lactation failure, alters lactation. The goal of the project is to expand our understanding of the basic mechanisms controlling milk secretion leading to therapeutic targets to treat lactation failure.